Molecular mismatch as a marker for immunologic risk in heart transplant recipients

PROJECT SUMMARY
The overall success of heart transplantation (HTx) as a lifesaving therapy for patients with end-stage heart
failure is attributable to the development and refinement of the current immunosuppressive drug regimens.
However, these agents carry well-known risks for malignancies, new onset diabetes, chronic kidney disease,
and other conditions that limit quality of life and long-term survival. The ability to titrate immunosuppression (IS)
to precisely match an individual recipient’s need would prevent both over-IS with its associated toxicities, and
under-IS with its risks of graft rejection. We propose to investigate the role of HLA eplet mismatches (EMM)
between donors and recipients as a biomarker for immunologic risk in HTx patients. In kidney transplantation
(KT), EMM analysis has been validated as such a biomarker, and established EMM thresholds defining high
and low risk categories are being used to guide IS. Since high-resolution HLA genotyping, required to calculate
EMM, has not historically been performed, the ideal prospective study of EMM in HTx would require long-term
follow-up and thus not yield meaningful results for several decades. To answer the question now, as to
whether EMM is a valuable biomarker for immunologic risk in HTx, we propose the use of three patient cohorts
which will provide complementary outcomes data with which to model associations between EMM and
immunoreactivity. In Aim 1 we will use a national dataset to impute high-resolution HLA genotyping based on
the low-resolution HLA typing that is captured in the registry. By leveraging population-specific high-resolution
haplotype frequency data and reported ethnicity, we will calculate imputed EMM for a large cohort (N=51,530)
of HTx recipients. Test imputations demonstrate good calibration when verified against known high-resolution
typing. We will evaluate the association of EMM with rejection, re-transplantation, and mortality captured in the
database. Using machine learning we will evaluate the EMM risk thresholds defined in KT patients and explore
ways to improve them for HTx recipients. In Aim 2 we will assess the association of EMM with cardiac allograft
vasculopathy (CAV), and with biopsy-proven rejection using a protocol HTx biopsy dataset. In Aim 3 we will
study a single-center observational cohort to examine the association of EMM with early indicators of
immunoreactivity in HTx recipients, including the development of de novo donor specific antibody and the
presence of donor-derived cell free DNA. There is an urgent need for a valid biomarker to gauge immunologic
risk in HTx recipients. Our use of existing and prospectively collected data from complementary patient cohorts
will enable us to evaluate EMM as a biomarker for HLA mismatch driven immunoreactivity. We aim to
demonstrate that EMM can be utilized to accurately and risk-stratify patients at the time of HTx. This work will
establish a foundation for future clinical trials that can fine-tune IS management, reducing the preventable
morbidity and mortality that accompanies both over- and under-IS.

Public health relevance
PROJECT NARRATIVE The toxicities of chronic immunosuppression are a known impediment to long-term survival after heart transplant, but optimally titrating immunosuppression would require a biomarker that reliably indicates immunologic risk. By analyzing three complementary cohorts – the national transplant data registry of all heart transplant recipients, an existing post-transplant heart biopsy archive, and a single-center observational cohort of heart transplant recipients – we will test the association between human leukocyte antigen (HLA) eplet mismatch and clinical outcomes including recipient and graft survival, rejection, and early indicators of immunoreactivity. An accurate biomarker for immunologic risk, particularly one that can be assessed at the time of transplantation, has been lacking in heart transplantation, and this work will test the hypothesis that eplet mismatch is that biomarker.